Countering sympathetic vasoconstriction during skeletal muscle exercise as an adjuvant therapy for DMD

Duchene muscular dystrophy (DMD) is an incurable neuromuscular disease characterized by
rapid muscle deterioration, mitochondrial and vascular impairments, resulting in premature loss
of ambulation and mortality. Emerging disease-modifying therapeutics aim to partially restore
levels of the missing sarcolemma protein dystrophin (critical for stabilizing and molecular
signaling). Although they are expected to improve muscle function and daily activity in boys with
DMD, most are not designed to correct the vascular impairment (since they do not restore nNOs
signaling which is needed to promote vasodilation during and after exercise). Thus, active muscle
of DMD boys treated with these therapeutics will have inadequate perfusion, causing injury and
fatigue despite partial dystrophin replacement. Tadalafil, an FDA-approved vasodilator drug has
potential to fill this therapeutic void; preclinical and clinical data show it improves perfusion, fatigue
and injury in mice with DMD, and post-exercise blood flow in boys with DMD. However, a phase
3 clinical trial assessing long-term tadalafil treatment in DMD failed to benefit the 6 minute walk
test (primary outcome), despite improved arm function. Based on lack of efficacy in the primary
outcome, tadalafil has been dismissed as a DMD therapeutic. We postulate that failure to account
for variable rates of ambulatory decline (which can affect the primary outcome) and tadalafil
engagement (which requires sufficient use of leg muscles) account for its lack of efficacy. Our
randomized, placebo-controlled Exploratory Clinical Trial will address these limitations and seek
proof of concept that tadalafil combined with structured exercise will improve muscle
pathophysiology and function in DMD. Our preliminary data show tadalafil can rescue activity-
dependent blood flow deficits in boys with DMD (aged 7-12 years). Our approach is to first screen
for drug responsiveness (increase in muscle oxygenation) after one dose. Those responsive will
be randomized to a 6-month intervention of tadalafil or placebo, combined with structured cycle
exercise training (to ensure regular muscle activation). We will quantify the intervention impact on
vascular impairment and muscle pathophysiology (inflammation, fat accumulation, mitochondrial
dysfunction), exertional fatigue and cycling performance. Our findings are expected to provide 1)
criteria to stratify DMD patients most likely to benefit from tadalafil as adjuvant therapy and 2)
demonstrate a powerful synergy between drug impact and exercise training in DMD. It aligns with
this R21 FOA as it will provide preliminary data to foster a robust, longer-term clinical trial using
vasodilator drugs and exercise training, with and without gene replacement therapies, that will
lead to clinically meaningful improvements in DMD treatment.

Public health relevance
Duchenne muscular dystrophy (DMD) is an incurable disease resulting in premature loss of ambulation and mortality, affecting males, with 400-600 newly diagnosed cases per year in the United States. Developing therapies aim to partially restore levels of the missing protein dystrophin, but most are not designed to correct impairments in blood flow regulation that are associated with the disease. This exploratory clinical trial study seeks proof of concept that tadalafil (a potent vasodilator drug) in combination with structured aerobic exercise will fill this therapeutic void by targeting both the vascular and muscle-based impairments, thereby improving exertional fatigue and function and allowing boys with DMD to live a more active lifestyle safely.